Developing and Pilot-testing a Yoga Program to Address Post-prostatectomy Side-effects Among Veterans with Prostate Cancer

Background: Prostate cancer (PCa) constitutes 30% of all new cancer diagnoses in the
Veterans Health Administration (VHA) and as such is the most frequently treated cancer among
Veterans. Those who are treated with radical prostatectomy (RP) often experience side effects
including erectile dysfunction (ED) and urinary incontinence (UI). The side effects of treatment often
persist for years and can contribute to anxiety and depression. Yoga, which includes breath work,
meditation, and physical poses, may be an effective intervention for treating side effects of RP. To
facilitate uptake and maximize its effectiveness, we propose to initiate the intervention prior to surgery
(prehabilitation) and deliver it using a blended approach (i.e., in-person and online sessions).
Significance/Impact: The VHA provides care to half a million cancer survivors, of which
nearly half are PCa survivors. This number is expected to grow as the population ages and treatments
become more effective. It is therefore critical for the VHA to understand how best to enhance the
quality and length of survival of those diagnosed with cancer. Furthermore, the VHA and Health
Services Research and Development program recognize the importance of using a “Whole Health”
approach to supporting the health and well-being of Veterans. This intervention aligns with the
purpose of Whole Health by partnering with Veterans to create a personalized yoga plan based on
their own goals and needs.
Innovation: The proposed intervention is innovative in several ways. First, it applies yoga to a
relatively new patient population (men with PCa) and sets of outcomes (ED and UI). Second, the
intervention is being tailored to the patient and delivered using a blended model. The first session is
in-person and used to tailor the yoga poses according to a Veteran's comfort and ability. Subsequent
sessions will take place online alongside ongoing patient cohorts. Third, the intervention includes a
prehabilitation component that aims to further dampen the side effects of RP.
Specific Aims: The long-term goal of this research is to optimize the QoL and patient
experience for men with PCa. To that end, we seek to assess the feasibility of an innovative blended
(in-person and online) yoga program and to obtain preliminary data on its potential effectiveness in
alleviating PCa treatment symptom burden. The specific aims are to: 1) determine the feasibility
(including demand, safety and acceptability) of the intervention for men receiving a radical
prostatectomy; and 2) obtain preliminary data to estimate the potential impact of the intervention on
ED and UI (primary outcomes), well-being (e.g., cancer fatigue, stress, anxiety), and QoL.
Methodology: For this pilot study, 30 Veterans who are undergoing a radical prostatectomy
for PCa treatment will be randomized to either the intervention or standard of care. The intervention is
a blended twice-weekly yoga program that includes a prehabilitation phase. ED and UI (primary
outcomes) as well as mental health well-being (e.g. stress, anxiety), including QoL (secondary
outcomes). Program uptake and attrition will be tracked and compared between groups. Baseline and
follow-up data on outcomes will be collected via survey. Safety will be closely monitored. Veterans'
experiences with and perceptions of the programs will be assessed through a post-intervention
survey.
Next Steps/Implementation: We anticipate that the intervention will be feasible, safe, and
acceptable to Veterans and provide some evidence of potential efficacy. Subsequently, we intend to
fully evaluate the efficacy of the intervention while exploring its broader adaptation in VHA.

Public health relevance
This year an estimated quarter million American men will be diagnosed with prostate cancer (PCa) including 14,000 men in the Veterans Health Administration (VHA). Men with localized PCa are often treated with surgery, a treatment that is associated with high rates of side effects such as erectile dysfunction (ED) and urinary incontinence (UI) which impact quality of life. Yoga may improve control of UI and improve ED by bringing awareness to and strengthening the pelvic floor musculature. The objective of the proposed randomized controlled pilot study is to assess the feasibility of an innovative hybrid (in-person and virtual) twice-weekly yoga program that includes a prehabilitation component and to obtain preliminary data that will help assess its potential effectiveness in alleviating PCa treatment symptom burden (primarily ED and UI). The long-term goal is to develop a scalable and sustainable yoga program that helps VHA cancer survivors manage their treatment side effects.